Advancing Suicide Intervention Strategies for Teens During High Risk Periods

Project Summary/Abstract
The proposed project is designed to evaluate the impact of two interventions designed to bridge acute care
and outpatient services in comparison with usual care. The long-term goal of this program of research is to
improve healthcare system’s response to youth who present to acute care due to suicide risk and effectively
reduce risk during the transition to outpatient care. The current study aims to evaluate treatment that begins
with Collaborative Assessment and Management of Suicidality (CAMS) or Safety Planning Intervention with
follow-up (SPI+). Adolescents, parents, and clinicians will participate in the project to advance to following
Research Aims: 1) Assess the comparative effectiveness of CAMS and SPI+ compared to usual care and 2)
Evaluate the mechanism of change accounting for the therapeutic effects of the interventions. The project
aligns with Strategy 3.2 and 3.3 in the NIMH Strategic Plan and the National Action Alliance for Suicide
Prevention Research Prioritization Task Force through the evaluation of interventions to optimize outcomes
in community practice settings.

Public health relevance
Project Narrative Discharge from acute care represents a period of heightened risk for suicide, and brief interventions during this transition have promise in enhancing longer-term outcomes. The interventions being compared in this proposal are feasible and currently in widespread use despite the lack of a rigorous trial of the interventions in youth. Data from this study will provide important data to help healthcare systems select and implement effective interventions to reduce the significant impact that youth suicide risk incurs on communities.